Comp C Spina Bifida Urologic Protocol at Vanderbilt Children's Hospital

PROJECT SUMMARY
Advances in medical care have increased longevity for babies born with spina bifida, the most common
permanently disabling birth defect in the United States. The main goals of the urologist participating in the care
or patients with spina bifida are: 1) to preserve normal renal function and 2) to ensure adequate bladder
continence for enhancing self-esteem and independence. Despite these common goals, practice patterns vary,
and best practices are not well defined. The Urologic Management to Preserve Initial Renal Function Protocol
(UMPIRE) has been designed to evaluate outcomes on a standardized urologic protocol from the neonatal period
to 10 years of age. The Spina Bifida Program at Monroe Carell Jr. Children's Hospital at Vanderbilt (MCJCHV)
evaluates approximately 20 newborns with spina bifida each year. The pediatric urology division at MCJCHV
has set the following goals for this study: 1) to approach each eligible patient in our program for enrollment, 2)
to contribute longitudinal data on diagnostic studies and interventions as specified by the protocol, and 3) to
evaluate data from UMPIRE to answer hypothesis-driven questions specifically about clinical predictors for
hostile videourodynamics and decreased renal function. The PI along with the clinical research coordinator will
ensure quality control of data submitted to the CDC. The PI has a demonstrated record of productive research
UMPIRE. Published results from this study will help to inform best practice clinical guidelines for urologic
management in the child with spina bifida

Public health relevance
PROJECT NARRATIVE Spina bifida, the most common permanently disabling birth defect in the United States, can have negative effects on bladder and kidney function. Although the main goal of urologic care in spina bifida patients is to preserve normal renal function, the best strategy for evaluation and treatment during childhood is not well understood with a fine balance between too many tests and interventions versus late recognition of a treatable problem. By contributing the urologic data from our Spina Bifida Program at Monroe Carell Jr. Children's Hospital at Vanderbilt to the Urologic Management to Preserve Initial Renal Function Protocol (UMPIRE) and by using the national registry data to answer questions about best and most efficient treatment, we hope to improve both health care utilization and outcomes for spina bifida patients.